Clinical Decision Support System for Early Detection of Cognitive Decline Using Electronic Health Records and Deep Learning

Project Summary
The prevalence of Alzheimer’s disease (AD) and related dementia (AD/ADRD) is expected to nearly triple to a
staggering 13 million affected Americans and the total costs of care are projected to increase five-fold to 1.1
trillion dollars by the year 2050. Early detection of precursor stages of AD/ADRD becomes extremely important,
as it can introduce treatment or intervention earlier for potential AD/ADRD patients, given existing treatments
only have modest benefit at best. Early cognitive decline of patients is often under diagnosed by primary care
physicians (PCPs). A clinical decision support (CDS) tool that can automatically detect cognitive decline signals
from longitudinal electronic health records (EHRs) and facilitate PCPs to make timely diagnoses would be highly
desirable, as it would result in early intervention for potential AD/ADRD patients. In our Phase I Equivalent work
at Harvard Medical School, we have developed a deep learning model for earlier detection of cognitive decline
using clinical notes in Mass General Brigham’s EHRs. Here we propose a Direct-to-Phase II study, which further
develops novel deep learning algorithms for the early detection of cognitive decline, implement them into a
clinical decision support tool, and validate the tool in a primary care setting. Specifically, in Aim 1, we will develop
novel ontology, NLP, and classification approaches to identify patients with early cognitive decline using records
from EHR and extract related evidence from clinical notes. In Aim 2, we will work with frontline physicians to
design, develop and evaluate a user-centered clinical decision support tool to identify and manage patients with
cognitive decline. The system, which we intend to align with evidence-based frameworks such as the CMS
Collaborative Care Model, will identify patients at risk (with supporting evidence) and prompt personalized
recommendations for timely care. Once the system is developed and fully tested, we will implement the
developed CDS tool in a simulated EHR environment at Mass General Brigham healthcare system, using real
patient data, and formally evaluate its utility and usability by recruiting primary care clinicians. This project will
deliver not only effective models for early detection of cognitive decline, but also a practical and validated CDS
tool that can improve diagnosis of precursor stages of AD/ADRD, thus facilitating early intervention for potential
AD/ADRD patients. If successful, it will be the first study that engages primary care physicians and real patient
data to validate the utility of such a cognitive decline detection tool.

Public health relevance
Title Clinical decision support system for early detection of cognitive decline using electronic health records and deep learning Project Narrative Early detection of precursor stages of Alzheimer’s disease (AD) and related dementia (AD/ADRD) is extremely important, as it can introduce treatment or interventions earlier for potential AD/ADRD patients. In this study, we will develop novel deep learning algorithms for the early detection of cognitive decline using Electronic Health Records, implement them into a clinical decision support (CDS) tool, and validate the tool in a primary care setting. The system will identify patients at risk (with supporting evidence from clinical notes) and prompt personalized recommendations for timely care. The system will assist primary care clinicians in detecting and managing patients who have cognitive decline.